Clinical, Molecular, and Genetic Determinants of MRI-determined Left Atrial Phenotypes

R01HL144707: PARENT +)' + ,'(+ * ,! %* +, &'(*,1 ,!' *(-) ' ,! +), %(/ +( ( ('(& +,,-+ !. %(/ * &(*,%,1 ,!' '(' +)' /!, + 3 ,! 4 +)' * (0 5 !+ +-*..% .', %' + /,! ,& ' ' *,(' /! ! !+ % ,( ,! )*()(+,(' ,!, *(+(' ( ! %,! -% % +,1% !,+ ' +( % * +(-* + (&' /,! ,! -&-%,. +,* ++ + ( && *,(' ,( * ! %,! (' ,- '% +,- + 0&'' ,! + ,(*+ * % $' , ,! +& ,& ,! * + . ' ,!, ,! +)' * (0 &1 '(, ))%1 ,( &#(* + + + +- * ! ! -* ' ( '(' % (!(% ,,1 %. * + + ' %- ' ,+ &(* .' (*& '(' % (!(% +, ,(! ),,+ /! ! + (&' ,! &(+, (&&(' -+ ( %. * ,*'+)%', ' ,! !+ ' -%, ,( +,- 1 !(/ . * -+ ,! '(++ !+ ) ' (' ()+1 !% %+( !. +)*()(*,(', -* ' ( ( +,1 ' , + ,!+ ( + '(, -%%1 (-', (* '/!% + (. *1 ( ,/( &#(* ' , .*',+ ,!, ', * * /,! ! ), %) )*( ++' -, ( '(, )* +)(+ ,( ( +,1 (* '+-%' * ++,' !+ ',*( - ,! (' ), ( 4 ' , 5 !+ &1 ( )*, -%* * % .' ,( -+ (' +- ! .*', + ! !%1 )* .% ', ' .*(-+ ! *, *(-)+ '%$ )* .% ' ( + %(/ * ' ,!' -, * 1+ -' ,(' ' ! *, %-* *+$ )) * ! ! * , *(& (-* *(-) -+' )*,% ( ,! %. * !+ %'$ ! ), *(++ ,( &1( * % *(++ * / /%% )*%1 ,! ())(*,-',1 (* ,!* 0& ( ,! +)' (&&-',1 %,! ,- 1 ,- 1 ( ,'(+ ' ,! +,* ' ,!+ ( (',*+, ,( * ++ &)(*,', $'(/% )+ ' ,!+ . *+ *(-) )%' ,( .%-, * %,('+ ( ',.,1 ' -*,(' ( * + ' /,! , *&' ! ), *(++ ' &1( * % +,*' /!% % . * ' %(' ,- '% ++ ++& ',+ ( % +,1% )+1 !(+( % ' +( ( -%,-*% ,(*+ ,( ++ ++ ,! * -&-%,. &) , (' ,! + )! '(,1) + ' ,( 0)%(* & ,(' ( && *,(' ' -%,-*,(' ,+ /%% %+( 0&' ,! (',*-,('+ ( .+ *% , ' %(/ )(' ,' % . %+ + / %% + ' , +-+ ),%,1 %(' ' ' (&',(' ,( ! ), *(++ +, / /%% .%-, ,! ++( ,(' ,/ ' ! ), *(++ ' &1( * % *(++ %(' /,! )*(' %&&,(*1 ' )*( ( -%', ,(*+ ,!, &1 %'$ ,! ,/( +(* *+ !+ +,- 1 /%% 1 % $ 1 '+ !,+ ',( ,! +)' * (0 ' ' ' ,! * !.(*% ' )+1 !(+( % , *&'',+ ' /%1 !* , *2 ,! -* ' ( ! ), *(++ ' ' ,+ ' , -' *)''' + ' '. +, , ,! %. * ! *, 0+ ' -' *%1' ),!/1+ + )(, ',%%1 + *(-+ ,!* , ,( ,! ! %,! ( ,!+ .-%' *% ,!' *(-)

Public health relevance
R01 HL 144707: PARENT PROJECT NARRATIVE Hispanics/Latinos are a large and diverse ethnic minority for whom immigration and assimilation to US culture may exacerbate behavioral and psychosocial threats, and weaken their social resources. There is evidence that Hispanics/Latinos may have more fatty liver disease than other ethnic groups, and that their burden of heart disease is underappreciated. This study will evaluate environmental and/or genetic influences on these disorders, assess their interrelationship, and provide information to improve the heart and liver health of this vulnerable population.